Systems Approach to Understanding Cardiovascular Disease and Arrhythmias - Cell diversity in the cardiovascular system, cell-autonomous and cell-cell signaling

UC Davis Cardiovascular Symposium
Systems Approach to Understanding Cardiovascular Disease and Arrhythmias
-Cell diversity in the cardiovascular system, cell-autonomous and cell-cell signaling-
Cardiovascular diseases, including hypertension, heart failure, arrhythmias and stroke, are the number one killer
in the developed world. In order to develop better and more effective therapies to treat heart diseases, it is
critically important for scientists and physicians to obtain in-depth and accurate understanding of the
mechanisms underlying heart and vascular function and dysfunction. In recent decades, researchers studying
heart and vascular diseases have been accumulating more and more experimental data from molecular, to
cellular, and to tissue and organ levels. However, there is a critical need to integrate these data into mechanistic
and quantitative models to understand emergent properties of complex biological system such as arrhythmias
and vasospasms that are often counterintuitive (due to non-linear dynamics interactions). Moreover, it is
important to understand how different cells of the cardiovascular system may interact with each other in
physiology and disease. Here we propose to take the necessary step forward to integrate experimental data into
quantitative models that enable using mathematical tools and computational power to understand the complex
interactions of the cells and molecules in the cardiovascular system. The unique design of this conference series
is to combine experimental study and mathematical modeling to achieve in-depth understanding of the dynamic
systems that control cardiovascular function and diseases. The proposed interdisciplinary conference is the 7th
in this series. This new installment of the conference will integrate, for the first time, studies in cardiac and
vascular tissue. The previous conferences have received overwhelmingly positive evaluations from attendees
and resulted in high impact publications. The proposed conference will combine experimental and modeling
studies in the field of cardiac and vascular physiology, with topics focused on cell diversity in the cardiovascular
system, as it is becoming increasingly evident that a complex interplay of abnormal signaling events among
various cell types, including myocytes, fibroblasts, endothelial, neuronal, immune cells, etc. plays a central role
in cardiovascular disease. The emphasis of this conference will be on (1) summarizing current state of research
in the focus area, (2) identifying consensus and controversy that warrant more investigation, and (3) exchanging
ideas, data, and information among the experimentalists and modelers to facilitate interdisciplinary collaborations.
The conference results will be summarized in the form of comprehensive review papers, which will be published
in leading scientific journals that have broad impact on the research community, as before.

Public health relevance
NARRATIVE Cardiovascular diseases including arrhythmias, heart failure, stroke and hypertension are prevalent causes of death in the United States and developed world. We propose to hold an interdisciplinary conference to bring together internationally renowned experimentalists and computational modelers in the cardiovascular research field. The goal is to achieve quantitative in-depth understanding of the molecular and cellular mechanisms that cause heart and blood vessel diseases. Understanding the disease mechanisms is critically important for developing new therapeutic strategies to effectively treat cardiovascular diseases. 1